Dynamic Cell-Matrix Interactions Dictate Thoracic Aortopathy

PROJECT SUMMARY – OVERALL PROGRAM
Thoracic aortopathy – aneurysms, dissection, and rupture – is increasingly responsible for significant morbidity
and mortality. Despite many seminal discoveries since 1991, when the genetic basis of Marfan syndrome was
uncovered, improvement in clinical care has largely remained limited to better identification of patients with
pathogenic variants who need monitoring of aortic diameter until intervention coupled with improvements in
surgical methods and devices. There is, therefore, a pressing need for improved understanding leading to
improved medical treatments. In this PPG, we will test the compelling overall hypothesis that aberrant vascular
cell-extracellular matrix (ECM) interactions that compromise tissue homeostasis are primary drivers of thoracic
aortic disease. That is, dysfunctional mechano-sensing and mechano-regulation of medial ECM by smooth
muscle cells results in a progressive deterioration of the biomechanical integrity of this critical layer of the thoracic
aorta, leading to progressive dilatation with possible dissection and rupture. Although such aortopathy often
arises due to a predisposing monogenic variant, secondary changes in cell signaling and gene expression can
represent either protective compensations or pathological consequences. In the absence of gene editing to
correct the predisposing variant, there is a need to distinguish and then preserve / promote compensatory gene
products while preventing pathological ones. In other words, there is a need (i) to identify and promote any
homeostatic processes that contribute to the remarkable resiliency of the aorta against incessant hemodynamic
stresses and that may similarly help to attenuate disease progression and (ii) to prevent secondary processes
that exacerbate disease progression, particularly in the presence of risk factors such as hypertension.
This PPG uses 3 Projects to elucidate roles of the 3 complementary nodes along the dysfunctional mechano-
biological axis and 2 Projects both to quantify effects of a primary risk factor (hypertension) and to provide high-
throughput integration and testing (experimental and computational) of findings across all main disease models
in order to better understand the underlying molecular, cellular, and biomechanical mechanisms of aortopathy
and to identify new actionable targets for treatment. Although highly complementary given our unifying central
hypothesis, each individual Project represents distinct, scientifically innovative, and significant research; two
Cores, one Administrative and one Scientific, will ensure close communication, collaboration, and consistent
data collection and analysis. The 5 Project leads have an established track record of highly productive
collaborations and contributions to vascular biology and thoracic aortopathy, and they have developed the
foundations for this work over a period of years, leading to intense activity over the past year to define this PPG.

Public health relevance
PROJECT NARRATIVE – OVERALL PROGRAM Thoracic aortic disease is increasingly responsible for disability and death in the US. Although much has been learned over the past three decades, clinical treatment has not improved proportionally. This project will bring together five complementary leading laboratories to identify opportunities for new treatment strategies motivated by a novel understanding of these diseases, namely, that they result from compromised interactions between the cells and constituents of the aortic wall that endow it with its strength.